Kabawil: Adapting an Intervention to Reduce Intersectional Stigmas among Indigenous Sexual Minority Men and Traditional Healers in Mesoamerica

SUMMARY/ABSTRACT
During the past decade in Latin America, new yearly HIV infections rose 21%, and as of 2022, HIV infections
were still rising. Of the 3.8 million people living with HIV in the Americas, 2.8 million live in Latin America. The
HIV epidemic continues to be highly concentrated among gay, bisexual, and other men who have sex with men
(GBM), especially in Mesoamerican countries such as Guatemala (9%), Belize (13.9%), Mexico (14.9%) and El
Salvador (16.3%). Research points to multiple co-occurring psychosocial and structural conditions, including
HIV- and sexuality-related stigmas that act as intertwined forces that potentiate HIV transmission among GBM.
This study addresses intersectional stigmas experienced by Indigenous GBM (IGBM) in Guatemala. This study
will adapt a patient-provider stigma-reduction intervention - Finding Respect and Ending Stigma around HIV
(FRESH). FRESH is workshop-based intervention that has been employed to reduce stigmas among healthcare
workers and GBM around the world, including a recent Spanish-language version in the Dominican Republic.
Guatemala is a diverse society in which close to 50% of the population identifies as Indigenous. Indigenous
Guatemalans who also identify as GBM, experience intersectional stigmas, including racial discrimination, which
increase vulnerability to HIV. Due to a crumbling public health system, and discrimination towards Indigenous
people at public hospitals, Indigenous traditional healers (ITH) are the first line of response to those seeking
health services. The adapted FRESH intervention, named KABAWIL in Maya K’iche language will be
implemented with IGBM and will include, for the first time, ITH. Our aims include: Aim 1: We will use the ADAPT-
ITT framework to adapt FRESH and produce the culturally tailored KABAWIL intervention. We will conduct in-
depth interviews (20 per group) and two focus groups with IGBM and ITH. Aim 2: We will use a randomized wait-
list control trial design to pilot test the intervention with 120 participants. Thirty IGBM and 30 ITH will be randomly
assigned to three KABAWIL intervention workshops (10 GBM + 10 ITH per workshop; n=60). The other 30 GBM
and 30 ITH will be assigned to the 3-month wait-list control. We will assess the intervention’s preliminary efficacy
on increasing HIV testing, PrEP uptake, PrEP/ART adherence, and decreasing experiences of stigma and
discrimination. Aim 3: Evaluate facilitators and barriers to the implementation of the KABAWIL intervention. We
will conduct a post-implementation, mixed-methods assessment guided by the Consolidated Framework for
Implementation Research (CFIR). We will conduct interviews with IGBM (n=10), ITH (n=10), and interventionists
(n=10) to identify contextual and organizational factors that may impact the feasibility and acceptability of the
intervention, and determine organizational/contextual fit for the design of a larger hybrid effectiveness
implementation trial to establish KABAWIL as a model for reducing intersectional stigmas and improve HIV
prevention and care for indigenous people throughout the Americas.

Public health relevance
PROJECT NARRATIVE Indigenous GBM in Guatemala experience intersectional stigmas, including racial discrimination, which increase vulnerability to HIV, and other health problems. This study will test the feasibility, acceptability, and preliminary efficacy on HIV and stigma outcomes of a culturally and contextually adapted stigma-reduction intervention for Indigenous GBM and traditional healers in Guatemala. Findings will inform the design of a large effectiveness implementation trial to establish KABAWIL as a model for reducing intersectional stigmas and improve HIV prevention and care for indigenous people in high-stigma, culturally conservative, resource-constrained communities throughout the Americas.